Joint genomic and statistical analyses of schizophrenia and bipolar to decipher genetic susceptibility

PROJECT SUMMARY
Although genome-wide association studies (GWAS) have been extremely successful in identifying numerous
germline variants associated to risk for schizophrenia and bipolar disorder, at the vast majority of these loci,
the causal mechanism between genetic variation and disease risk remains unknown. This limits the
development of novel drug targets and/or personalized treatments. Schizophrenia and bipolar disorder share
many genetic risk loci thus motivating approaches to gain insights into the shared molecular basis of these two
diseases. Post-GWAS studies are experiencing a “big data” revolution driven by the exponentially decreasing
costs of high-throughput genomic assays, including transcriptome levels, epigenetic modifications, and
localization of tissue-specific regulatory sites, which are being collected in increasingly large cohorts of
individuals. Here we propose a rigorous framework aimed at loci where shared or disease-specific risk for
schizophrenia and bipolar disorder is mediated through alteration in gene expression levels, regulated via
epigenetic control. To increase power for discovery while also facilitating validation of new findings, we will
generate new disease-specific expression and chromatin variation data in subjects with known disease status.
We propose to examine risk loci for schizophrenia and bipolar disorder to prioritize causal variants and genes
and to validate them in functional assays.

Public health relevance
PROJECT NARRATIVE Genetic studies of schizophrenia and bipolar disorder have been tremendously successful in identifying regions in the genome harboring genetic susceptibility for disease but the underlying biological mechanisms remain elusive. In this proposal we will develop and apply new statistical and experimental methods to identify causal risk alleles and genes with their underlying mechanisms that contribute to the shared and disease- specific risk of these common neuropsychiatric disorders.